Long-term Oral Complications of an Established Head and Neck Cancer Cohort- Clinical Registry of Dental Outcomes in Head and Neck Cancer Patients: OraRad

PROJECT SUMMARY/ABSTRACT
Most head and neck cancer (HNC) patients receive high-dose radiation therapy (RT), which has
significant, sometimes life-long, adverse effects on oral and maxillofacial tissues. Damage to
salivary glands frequently leads to hyposalivation, increasing the risk of dental caries and tooth
loss post-radiation. Furthermore, radiation impairs the ability of bone to heal, leading to a life-
long risk of osteoradionecrosis (ORN), which presents as exposed intraoral bone and is often
precipitated by dental extractions. Consequently, HNC patients are caught in a vicious circle,
being at higher risk of needing dental extractions, but with extractions to be avoided post-RT
due to the risk for ORN. A multi-center prospective cohort study, Clinical Registry of Dental
Outcomes in Head and Neck Cancer Patients (OraRad), was established to examine the
incidence of oral complications after RT and associated risk factors in HNC patients. The
OraRad cohort of 572 participants was followed for 24 months with incidence and risk factors of
short-term oral complications identified. The overall objective of the current proposal is to
assess OraRad participants at 7 years post-RT and identify the long-term incidence and risk
factors of oral complications in this cohort. We will accomplish this objective by pursuing the
following specific aims: 1) Determine the long-term incidence of dental caries, periodontal
disease, tooth loss and osteoradionecrosis, up to 7 years after RT for HNC patients and 2)
Determine the risk factors associated with high and low incidence of long-term oral
complications and develop a multiple variable model of risk. We will accomplish these aims by
having current OraRad participants return for a clinical oral examination at about 7 years post-
RT. We anticipate 350 long-term OraRad survivors will be evaluated at this follow-up visit. The
proposed research is innovative because this is the first prospective multi-center study with a
large enough sample to identify risk factors associated with long-term adverse dental outcomes
in HNC patients after modern RT. Our strong data on the incidence and risk factors of oral
complications for the initial OraRad 24-month study period clearly demonstrate the feasibility of
achieving these aims. This study is highly significant because it will directly provide data to
facilitate evidence-based dental management of patients receiving current modalities of RT for
HNC.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will directly provide data to facilitate evidence-based dental management of head and neck cancer patients receiving current modalities of radiation therapy, which is expected to lead to improved clinical outcomes. The proposed research is directly responsive to PAR-20-060 (which specifically mentions cohort studies prospectively assessing risk factors for disease development). It will also help to achieve Objective 1-3 of the 2014-2019 NIDCR Strategic Plan: “To conduct translational and clinical investigations to improve dental, oral, and craniofacial health”.